A Novel Pathogenic Pathway for Diabetic Keratopathy

Diabetes Mellitus (DM) is a major public health problem and one of the most prevalent chronic diseases
worldwide. DM ocular complications, diabetic retinopathy and diabetic keratopathy, are eminent risk factors for
visual deterioration in DM patients. Diabetic keratopathy is characterized by epithelial lesion, reduction of
epithelium thickness, oxidative stress, inflammation, decreased corneal nerve densities and declined corneal
sensitivities. The pathogenic mechanism for diabetic keratopathy is not fully understood, which represents a
major knowledge gap. Peroxisome Proliferator-Activated Receptor-α (PPARα) is a ligand-activated transcription
factor and a key regulator of lipid metabolism. Two large and prospective clinical studies reported independently
that the PPARα agonist fenofibrate has robust therapeutic effects on diabetic retinopathy. However, the
implication of PPARα in diabetic keratopathy remains to be investigated. Our studies in the past grant period
have demonstrated that: 1) PPARα levels are decreased in the corneas of diabetic human donors and of a
diabetic animal model. 2) Fenofibrate alleviates corneal nerve degeneration and decline of corneal sensitivity in
diabetes. 3) PPARα ablation alone induces corneal nerve degeneration. 4) Primary stromal cells from diabetic
human donors showed decreased neurotrophic secretion. 5) PPARα KO reduces production of neurotrophic
factors in the cornea. To investigate the molecular basis for these PPARα functions, our preliminary studies
found that fenofibrate prevents corneal mitochondrial dysfunction in a diabetic model, while PPARα KO
decreases mitochondrial function and contents in the cornea. This project will address a hypothesis that the
protective effect of PPARα against diabetes-induced corneal keratopathy and nerve degeneration is through
normalization of metabolic dysfunction in corneal cells and improving the neurotrophic microenvironment in the
cornea. We will investigate if activation or overexpression of PPARα will alleviate keratopathy and metabolic
deficiency in the diabetic cornea, while PPARα ablation in the cornea will exacerbate corneal nerve degeneration
and keratopathy in diabetes. We will also investigate the molecular mechanisms for the corneal
epithelium/stroma-nerve interactions, using established 3D in vitro and in vivo models. We will also determine if
PPARα promotes innervation via upregulation of neurotrophic factors in extracellular vesicles (EVs). In primary
human epithelial and stromal cells, we will determine if PPARα prevents metabolic deficiencies induced by
diabetic stressors. We will also investigate the role of PPARα in the modulation of autophagy/mitophagy and
cGAS-STING signaling in the corneal epithelium/stroma. The proposed studies will identify a novel function of
PPARα in the regulation corneal metabolism and a new pathogenic mechanism for diabetic keratopathy. The
hypotheses to be addressed here challenges the prevailing paradigm of diabetic keratopathy, and the findings
from this project will have the potential to reframe the future treatment modalities. Thus, this project has high
translational potential and may lead to a new therapeutic strategy for diabetic keratopathy.

Public health relevance
PROJECT NARRATIVE Approximately 380 million people worldwide are suffering from diabetes mellitus, and the majority of them will encounter corneal defects at some point in their life. We propose to investigate the role of PPARα in human diabetic keratopathy and diabetic neuropathy, using novel and established in vitro and in vivo models. The proposed studies have potential to identify a new therapeutic target for prevention or treatment of diabetic corneal complications.